Characterizing Biological Aging for Heart and Lung Diseases Using Multi-omics Ageotypes

PROJECT SUMMARY/ABSTRACT
As the aging population continues to grow worldwide, age-related chronic heart and lung diseases have become
an increasingly serious public health issue. Consequently, understanding the relationships between aging and
these diseases is crucial for effective prevention and treatment strategies. However, the complexity of the aging
process, which involves cellular senescence, inflammatory responses, and oxidative stress, and its differential
impact on individuals, makes it difficult to identify the relationship between specific aging processes and the
development of various heart and lung diseases. The recent concept of "ageotypes," which clusters individuals
into similar molecular profiles throughout the aging process, offers a framework to identify molecular mechanisms
of aging and connect this with chronic heart and lung diseases. However, existing studies of ageotypes have
been limited by small sample sizes, short follow-up periods, and insufficient omics data, limiting their overall
utility. This proposal aims to generate multi-omic ageotypes to understand the molecular mechanisms of aging
that lead to chronic heart and lung diseases. The overall objectives of this proposal are to: 1) develop and validate
multi-omic ageotypes using metabolomics and epigenetics data in two large cohorts with electronic medical
records (EMR) data; 2) identify the molecular drivers that significantly contribute to each ageotype, particularly
in relation to heart and lung diseases; 3) elucidate the relationship between ageotypes and chronic heart and
lung diseases. Through personalized approaches for different ageotypes, we may not only improve the treatment
of chronic heart and lung diseases but also potentially delay or prevent their onset, thereby having a profound
impact on public health.
Dr. Yulu Chen is a bioinformatician specializing in using multi-omic approaches to study complex disease
phenotypes, particularly respiratory diseases and aging. Her overarching career goal is to become an
independent researcher with the skills to enhance the biological understanding and clinical management of aging
and related heart and lung diseases through integrative omics techniques. Dr. Chen's strong quantitative and
methodological background, combined with the support from a diverse and world-class mentoring and advisory
team from the Channing Division of Network Medicine at Brigham and Women’s Hospital and Harvard Medical
School, has well-prepared her for the proposed research. The proposed career development plan builds on her
previous training and outlines five training objectives to enhance her trajectory toward becoming an independent
researcher: 1) expand her skills in integrative omics techniques, particularly network-based approaches for
integrating multi-omic datasets; 2) enhance her knowledge and application of epigenomic data; 3) gain a deeper
understanding of the phenotypes and experimental measurements of heart and lung diseases; 4) broaden her
understanding of the biological mechanisms of aging; 5) improve her skills in research design, mentorship,
scientific ethics, and research communication.

Public health relevance
PROJECT NARRATIVE As the global population ages, chronic heart and lung diseases have become a major public health burden that underscores the need for more effective approaches to treatment and prevention. However, the complexity of the aging process and the variability among individuals make it difficult to identify the relationship between different aging processes and the development of specific heart and lung diseases. This proposal aims to develop a new framework for understanding aging mechanisms by generating "ageotypes" that group individuals by similar multi-omic profiles and improve the ability to identify specific molecular mechanisms of aging and their connection to chronic heart and lung diseases, thereby providing a scientific basis for personalized prevention and treatment strategies.